VU BMS 2 PHASE I STUDY OF BMY-40481 30 MINUTE INFUSION DAYS 1-5

Determine the maximum tolerated dose, identify the dose limiting toxicities and evaluate the pharmacokinetics of BMY-40481 at different doses.